Innovative implementation of artificial intelligence techniques for enhanced management of aortic abdominal aneurysms

ABSTRACT
Abdominal aortic aneurysms (AAAs) are a significant healthcare challenge, particularly among the elderly.
The presence of intraluminal thrombus (ILT) is common in AAAs, yet its precise role in aneurysm progression
remains a topic of ongoing debate. Emerging evidence suggests that ILT substantially contributes to AAA growth
by creating an environment that promotes proteolytic activity, leading to the degradation of elastin and collagen
in the arterial wall. Despite recognition of the role of blood flow patterns in ILT formation and AAA progression,
a systematic approach to understanding these relationships is lacking.
This study aims to bridge this gap by investigating both gross and local blood flow characteristics to uncover
the mechanisms underlying ILT initiation and subsequent AAA rupture risk. Leveraging my expertise in
computational modeling, along with new training in deep-learning-based image processing and statistical
analysis, this research will examine the spatiotemporal dynamics of hemodynamics and their correlations with
ILT development. Machine learning (ML) algorithms will be utilized to analyze global flow indices and near-wall
flow characteristics, enhancing our ability to predict ILT formation and AAA rupture risk.
The study will first identify general blood flow characteristics linked to ILT development, followed by an in-
depth analysis of local hemodynamics in distinct sub-regions of the aneurysm to reveal their specific roles in
localized ILT formation and AAA expansion. Finally, both global and local flow characteristics will be integrated
using ML to establish a relationship between hemodynamics, ILT accumulation, and rupture risk. Through this
comprehensive exploration, the study seeks to provide a more coherent understanding of AAA severity and the
interplay between blood flow, ILT, and rupture risk.
Overall, this project aims to bridge the gap between aneurysmal hemodynamics, ILT formation, and AAA
rupture risk, offering new insights for clinical management and risk assessment of AAA patients. This fellowship
will further enhance my expertise in AI-driven medical image processing and statistical analysis while fostering
collaboration with clinical experts to advance my career in vascular research.

Public health relevance
Narrative Abdominal aortic aneurysms (AAAs) are life-threatening conditions influenced by intraluminal thrombus (ILT), which contributes to arterial wall degradation and increases the risk of rupture. This study will explore the link between hemodynamics, ILT formation, and AAA rupture by integrating computational modeling, machine learning-based data analysis, and deep learning-based image processing techniques. It aims to enhance risk assessment and clinical management strategies for AAA patients, bridge crucial gaps in understanding disease progression, and pave the way for improved patient outcomes.